Evaluating the efficiency of in vivo gene transfer to correct the molecular neuropathology causing psychiatric disease in MSUD

Project summary
Maple Syrup Urine Disease (MSUD) is an autosomal recessive amino acid metabolism disorder that is regarded
as the most severe amino acidopathy and is invariably fatal if left untreated. MSUD is caused by buildup of the
branched chain amino acids (BCAAs) leucine, isoleucine and valine. The current standard of care for MSUD is
either BCAA-free formula diet or liver transplantation. MSUD liver transplantation does do not reverse prior
damage to the CNS, does not prevent the low IQ, ADHD or the profound psychiatric disease, which is
unresponsive to antidepressants. MSUD also naturally occurs in calves, and the disease is strikingly similar to
humans both in disease course, biochemistry and post-mortem analyses. In proof-of-concept data we treated
an MSUD calf by intravenous adeno associated viral (AAV) gene therapy and our therapeutic response was
equivalent to that of the standard of care (liver transplant or formula diet) in MSUD patients. However, the calf
exhibited white matter abnormalities on MRI like that of MSUD patients, low glutamate on MR spectroscopy and
in cerebrospinal fluid, also consistent with human MSUD. Therefore, this proposal focuses on addressing the
neurological aspects of MSUD while maintaining the biochemical correction in the periphery. Our team consists
of Dr. Dan Wang, an AAV gene therapy expert that tested this therapy in MSUD mice and showed profound
efficacy, Dr. Guangping Gao the director of the Horae Gene Therapy Center who has subsidized the cost to
make sufficient amounts of AAV to treat MSUD calves and Dr. Kevin Strauss, the physician who cares for all
the MSUD patients and has pioneered all the therapeutic approaches for MSUD including liver transplant and
developed the MSUD formula. Dr. Gray-Edwards (PI) is an expert in large animal AAV gene therapy and has
taken several AAV gene therapies to the clinic through testing in large animal models of human genetic diseases.
The experimental aims of the proposal is as follows:
Aim 1: Determine if high dose intravenous or combined intravenous and CSF delivery of AAV9-A-BiP-B can
address the neurological components of MSUD.
Aim 2: Long term assessment of the best AAV gene therapy approach
Aim 3: Underpinning transcriptomic and metabolomic changes in the MSUD brain receiving the standard of care
and determining the effect of gene therapy.

Public health relevance
Project Narrative Maple Syrup Urine Disease (MSUD) is a fatal and untreatable metabolic disease that is only treated by drinking a formula diet for life or getting a liver transplant. Even after these treatments, MSUD patients suffer from untreatable depression, attention deficit disorder (ADHD) anxiety and low IQ. Here we test a gene therapy in cows with MSUD to prevent the need for liver transplant or special formula diet that also prevents the depression ADHD, anxiety and low IQ.